Role of R-loops in transcriptional stress, genome instability, and chronic immune response in Alzheimer's disease

Advanced age is a major risk factor for many chronic diseases, including Alzheimer’s disease (AD). Despite
substantial research progress, most treatments currently available merely mitigate symptoms. Given that most
of patients with dementia due to AD are sporadic, and in those, aging is the key risk factor for this late-onset AD,
targeting the mechanisms that have been collectively summarized as “hallmarks of aging” may provide avenues
for development of new therapeutic approaches. Emerging evidence links aging and age-related
neurodegenerative diseases to disruption in RNA alterations, specifically N6-methyladenosine (m6A)
modification. m6A RNA is the most prevalent and abundant modification of RNA in eukaryotes, with high
expression specifically in the brain. Recently, m6A RNA has been shown to regulate stability of R-loops; three-
nucleic acid structures, consisting of an RNA-DNA hybrid and a ssDNA that form during transcription.
In this proposal we will examine the role of m6A epi-transcriptomic modification in R-loop-driven pathophysiology
of AD. Using Drosophila AD model, in aim 1 we will elucidate how m6A RNA impairment impacts R-loop
distribution across the genome and formation of RNA-DNA hybrids in cytoplasm, and their impact on
transcriptional stress and activation of chronic immune response in AD. The significance of aim 2 is in identifying
the regulatory mechanisms of R-loop-dependent DSB formation in AD. While variety of exogenous factors can
contribute to DNA damage, we will define a role of R-loops in genome instability associated with AD. Moreover,
we will define the epigenetic modifications associated with formation of stable R-loops resistant to resolution,
which are alternatively processed into DSBs. In aim 3, we will expand our studies from Drosophila to mammalian
system. Using in vitro rat cortical neuron cultures seeded with human brain tau, we will further elucidate the
molecular mechanisms of R-loop associated genome instability and neuroinflammation in AD. Neurons have
specialized RNA metabolism and it is therefore not surprising that dysfunction in RNA metabolism is strongly
associated with neurological diseases.
This proposal focuses on a novel possibility that defects in RNA metabolism, and particularly R-loop
homeostasis, is a significant driver of transcriptional stress, genome instability, and chronic immune response;
key hallmarks of aging, whose acceleration may lead to neurodegeneration.

Public health relevance
Aging is a key risk factor for many chronic diseases, including Alzheimer’s disease. This proposal aims at examining the role of R-loops in mechanisms of transcriptional stress, genome instability, and chronic immune response; all hallmarks of aging. Successful completion of proposed aims should provide new avenues for therapeutic approaches targeting these hallmarks, and thus slowing down onset or progression of neurodegenerative disease.